"1/6" Planning for HEALthy Early Development Study

PROJECT SUMMARY The Planning for the HEALthy Early Development Study will contribute to the design and recommended protocol for a future large-scale, multi-site research study to prospectively examine human brain, cognitive, behavioral, social and emotional development of children beginning prenatally through ages 9-10, and to determine the impact of maternal pre- and postnatal substance use on short- and long-term development of children. The Planning Study will link investigators across 6 research sites who have complementary experience and expertise in the areas that are essential to designing the study. Planning activities will be accomplished using a coordinated set of 10 Working Groups who will work collaboratively to design a sampling and recruitment strategy for a future large-scale study, to identify and recommend strategies for addressing the challenges to ethical recruitment and retention of vulnerable populations, and to develop and test a common protocol for neuroimaging, infant and child assessments, exposure assessment, biospecimen collection, and integration of novel technologies. By the end of the Planning Phase, the 6 Consortium sites will have produced and tested a recommended protocol for the future multi-site study, and will have established feasibility of carrying out the study protocol at each of the 6 linked sites.

Public health relevance
Narrative This research proposal supplements a parent grant with aims of designing a large scale multi-site longitudinal study of prenatal drug and environmental effects on brain development and behavior that will enroll pregnant women and mothers and their infants. This study will assess the impact of the current COVID-19 virus on substance use behavior, psychological distress and coping behaviors of women to be enrolled in the longitudinal study so that any barriers to enrollment can be addressed prior to launching the large scale study.